New York Regional Center for Diabetes Translation Research

The overall goal of the Population Health and Health Systems (PHHS) Core is to promote high quality diabetes-related translational research within the community and health system settings. The PHHS Core will continue to support obesity and diabetes investigators, health systems, and public health and community organizations to develop and disseminate translational research programs that improve patient and population health. Through effective collaboration with expert, multidisciplinary faculty, the PHHS Core will seek to improve uptake of research findings into policy and practice to more rapidly disseminate effective models across community and health care settings, thereby increasing potential for sustainable improvements in diabetes-related outcomes. PHHS Core services include: facilitating access to multi-level data that can inform diabetes-related health, providing expertise in innovative analytic methods and study designs for complex systems, and facilitating access to community and health system partnerships that can inform implementation and sustainability of best practices. The specific aims of the PHHS Core are: 1) provide community engagement expertise leveraging public health, health systems, and community-based partnerships to accelerate innovative diabetes translation research across the region; 2) provide consultation and technical support for health systems research that promotes efforts to develop, sustainably implement, rigorously evaluate, and disseminate effective diabetes prevention and management interventions; and 3) provide consultation and guidance to investigators in analytic methodologies, using big data to inform interventions that address factors that influence health, systems, and policy. Through our partnerships, we will promote collaboration and provide technical support to translational investigators, health systems, and public health colleagues to further their efforts to inform health-related policy, develop, implement, rigorously evaluate, and disseminate effective diabetes prevention and management interventions in communities at risk and within health systems. In this new funding cycle, we plan to attract more investigators working with clinical and community populations with an interest in addressing the population- community- and health system-factors that influence diabetes health outcomes. We will also engage community partners as part of a team science approach to disseminating best practices in obesity and diabetes prevention and control.